Type 1 Diabetes TrialNet Clinical Network Hub

PROJECT SUMMARY / ABSTRACT
TrialNet's mission is to bring disease modifying therapy to clinical use in type 1 diabetes (T1D) with a primary
focus on conducting clinical trials at early stages of disease to prevent or delay clinical onset. TrialNet is an
international consortium of twenty-five Clinical Centers and hundreds of Affiliate sites in US, Canada, UK,
Sweden, Finland, Germany, Italy, and Australia. These sites together with the TrialNet Coordinating Center
(TNCC), the TrialNet Clinical Hub (HUB), and members of our Collaborative Mechanistic Studies Panel (CMSP),
(a) conduct natural history studies to describe the progression of T1D and identify individuals for clinical trials,
(b) conduct clinical trials of disease modifying therapy both prior to and after clinical diagnosis, and (c) increase
the scientific value of trials through mechanistic studies involving investigators within and external to TrialNet.
The mission of the Type 1 Diabetes TrialNet Hub is to increase the efficiency of critical Network activities by
supporting collaborative and innovative approaches for screening, recruitment, retention, trial development and
implementation, and dissemination of results.
With considerable success during the previous grant period, this application describes our proposal to continue
to serve as the Diabetes TrialNet Clinical HUB. We focus on three areas; activities to (a) enhance risk screening
to identify at-risk individuals, (b) enhance enrollment and retention in clinical trials, and (c) enhance clinical
administration to effectively implement TrialNet's goals.

Public health relevance
PROJECT NARRATIVE Diabetes TrialNet is an international clinical trial network aimed to delay or prevent the onset of type 1 diabetes. This is an application from Dr. Greenbaum and the Benaroya Research Institute to continue to serve as the Diabetes TrialNet Clinical Hub whose activities are designed to facilitate achieving this goal by increasing efficiencies for identifying at-risk individuals, enrollment, and retention in trials; and disseminating results. The Director of the Diabetes TrialNet Clinical Hub will be part of the TrialNet leadership team including representatives of the NIH, the TrialNet Coordinating Center, and TrialNet chairman.